Targeted Modulation of Longevity-Associated Genes Using Antisense Oligonucleotides

Project Summary
Aging is a major risk factor for many chronic diseases including diabetes, cardiovascular disease, cancer, and
neurodegenerative diseases, as well as for geriatric syndromes including frailty and sarcopenia. Therapeutics
that delay and/or slow the progression of aging, and thereby increase healthspan and longevity, have
remained elusive. Over the past several decades, genetic studies in model organisms and humans have
identified and validated a number of longevity-associated genes. A notable subset of these genes function in
the somatotropic axis that signals nutrient status and thereby regulates growth and metabolism. Together,
these findings strongly suggest that modest changes in the expression levels and/or activities of these genes
can have significant impact on healthspan and lifespan. Despite this strong genetic basis, how to
pharmacologically modulate levels of these genes in vivo has been a major challenge. Fortunately, antisense
oligonucleotides (ASOs) are emerging as a promising therapeutic modality, and they enable highly specific
modulation of target protein levels in vivo. Leveraging recent advances in ASO technology, we are now well
poised to target longevity-associated genes in vivo. In this project, we will: 1) design and test ASOs to
modulate the levels of four longevity-associated genes, and 2) test if the ASOs can extend lifespan and
improve healthspan using a mouse model of accelerated aging. Completion of these studies will provide
important insights into the utility of ASO-based therapeutic approaches for modulating levels of longevity-
associated genes to improve healthspan and increase longevity.

Public health relevance
Project Narrative Over the past several decades, genetic studies in animal models and in humans have identified and validated a number of longevity-associated genes. Together, these findings strongly suggest that modest changes in the expression of these genes can have significant impact on healthspan and lifespan. In this project, we will develop antisense oligonucleotides to modulate the levels of selected longevity-associated genes, and then test if they can extend lifespan and improve healthspan using a mouse model of accelerated aging.